Task A57:MOUSE MODEL FOR EVALUATION OF COUNTERMEASURES AGAINST MERS

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.